The 3E Study: Economic and Educational Contributions to Emerging Adult Cardiometabolic Health

PROJECT SUMMARY/ABSTRACT
College is a time of changing socioeconomic position (SEP) that is not often clearly captured in
health research, despite strong ties between SEP and health. Over one-third of college students
report being overweight or obese, and the incidence of cardiovascular disease outcomes
among young adults has been an increasing cause of concern. This risk is exacerbated for
low-SEP students, and students of color, especially since the COVID-19 pandemic began. The
proposed longitudinal research addresses these important scientific gaps by creating and
studying a de novo, longitudinal cohort of 4,000 racially, ethnically, and socioeconomically
diverse young adult college students recruited as first-year students from two HSIs in California
and followed over three years, regardless if they leave or stay in college. To best recruit and
retain students, an undergraduate student researcher from the population of interest will
provide insight into how best recruit and retain study participants. They will conduct a literature
review on how best to recruit and retain students from racially diverse campuses with high
proportions of students who are pell grant eligible and the first in their family to go to college
and assist in creating and modifying recruitment and retention materials that are culturally
appropriate, ethical and effective. The study will incorporate anthropometric, institutional
administrative, smartphone, behavioral, and self-reported data. The specific aims are: (1) To
determine the contribution of emerging adults’ economic stressors (e.g.,income, wealth,
financial stress, basic needs, residential environment, subjective social status) to
cardiometabolic health outcomes (e.g., weight-related measures, blood pressure) over time; (2)
To determine the contribution of educational protective factors (e.g., use of social supports,
academic supports, basic needs supports) to cardiometabolic health outcomes over time; (3)
examine weight-related behaviors (i.e., sleep, physical activity, diet, disordered eating, smoking)
as mechanisms of associations between economic stress, educational protective factors, and
cardiometabolic health. This large, diverse sample will allow us to examine how racialized and
gendered identities may modify associations between economic and educational exposures and
cardiometabolic outcomes, which will help increase understanding of the complex interplay
between different social determinants of health and help inform potential interventions to
reduce health disparities.

Public health relevance
Project Narrative Recruiting and retaining study participants from a racially and ethnically diverse student body is imperative to the success of longitudinal research in the health and education fields. This diversity supplement will not only expand access to research to an underrepresented student, but by including a student from this very population it will help the research team ensure we produce recruitment and retention materials that are culturally appropriate, ethical, and effective. This will help us reach our larger goal of better understanding how economic and educational factors impact emerging adult cardiometabolic health.